POG 9571 IRINOTECAN IN CHILDREN WITH SOLID TUMORS

Determine qualitative and quantitative toxicity of irinotecan administered as IV infusion, establish maximum tolerated dose that results in tolerable toxicity, characterize the pharmacokinetics and observe anti-tumor effects during escalating dose of drug.